State-of-the-art housing to expand the Emory National Primate Research Center SPF rhesus macaque breeding colony

Abstract
The robust nonhuman primate research portfolio at the Emory National Primate Research
Center (ENPRC), which reached $36.8M in FY2022, has placed significant and unsustainable
demands on the Emory NPRC rhesus macaque SPF breeding colony. To meet the current and
projected future research demand, ENPRC is proposing to build new animal housing at the
ENPRC Field Station to facilitate expansion of the SPF breeding colony. The new animal
housing proposed will be a novel housing design that integrates traditional large indoor/ outdoor
breeding spaces into a building that includes smaller run housing space as well as animal
support space. The run housing will be comprised of traditional indoor run space with
accompanying enlarged outdoor run space to facilitate larger social groupings. This
combination of compound and run space will maximize breeding potential and facilitate targeted
genetic breeding in run groups to support specific research requests and enable colony
management needs. The new building will enhance animal welfare with natural substrate in the
runs as well as the outdoor compound and include functional features incorporated into the
design that will improve animal handling and increase efficiency for personnel. The proposed
new animal housing at the Field Station will allow for significant expansion of the SPF rhesus
macaque colony over the next five years, thus providing additional animals to support the
current research and projected research program for investigators at Emory NPRC as well as
for external collaborators to address the nationwide shortage of NHPs for research.